Engineering potent antibodies against human cytomegalovirus

SUMMARY
Human cytomegalovirus (CMV) is an enveloped, double-stranded DNA beta-herpes virus that has co-evolved
with humans for ~200 million years. Over 90% of octagenarians are seropositive for CMV antigens, often with
no knowledge that they harbor the virus. While its prevalence goes relatively unnoticed by the general public,
CMV is the primary infectious cause of congenital birth defects and causes significant morbidity and mortality in
immunocompromised individuals. Despite considerable effort, the many therapeutic antibodies and vaccines
evaluated in clinical trials have not progressed, while commonly used antivirals have significant toxicities and
induce resistance. The largest vaccine trial to date observed ~50% efficacy, which correlated with non-
neutralizing antibody responses, suggesting key roles for antibody-dependent effector functions in protection.
A challenge in developing CMV antibody therapeutics and vaccines is the arsenal of immune evasion strategies
deployed by this virus. Antibody MSL109 failed phase II trials apparently due to an escape mechanism that
resulted in new viral particles being coated with MSL109. The mechanism appeared to involve viral proteins that
bind human IgG Fc domains (viral Fcg receptors or vFcgRs) and impeded antibody effector functions by blocking
interactions with host Fcg receptors on immune cells. We hypothesize that blocking antibody capture by viral
Fcg receptors will enhance protection by anti-CMV antibodies. We will evaluate this hypothesis using two
complementary aims with translational relevance. Aim 1 will engineer the human IgG1 antibody Fc to identify
variants that resist vFcgR capture and could be incorporated into future anti-CMV therapeutics, while Aim 2 will
evaluate the ability of antibodies whose Fab domains bind the vFcgRs to block Fc capture and thereby enhance
antibody protection. The antibodies produced in this project will be rigorously characterized in vitro for antigen
and host Fc receptor affinities, the ability to mediate antibody-dependent cellular cytotoxicity and prevent viral
spread using CMV-infected cells in vitro since there is no simple animal model of CMV disease.
The long-term goal of this research is to support development of potent antibody therapeutics and vaccines
that prevent cytomegalovirus disease in high-risk populations, including newborns and organ transplant
recipients. The specific objective of this proposal is to determine the impact of antibody Fc capture on anti-
CMV antibody activities and the potential for strategies blocking these interactions to eliminate CMV-infected
cells and prevent viral spread. The expected outcomes include (i) engineered human IgG1 Fc variants that
resist capture by the two best characterized vFcgRs and (ii) determining the increased protection that can be
gained by blocking Fc capture. This project will provide insights into a key CMV immune evasion strategy and
the contributions of Fc-dependent functions to CMV protection with relevance for future CMV therapeutics.

Public health relevance
NARRATIVE Cytomegalovirus (CMV) is a widespread virus that causes mild illness in healthy individuals but can cause serious disease in newborns, seniors and the immunocompromised. Multiple antibodies and vaccines to prevent CMV infection have failed in the clinic, which we hypothesize is at least partly due to the virus’ ability to capture and destroy anti-CMV antibodies. This project will evaluate strategies to disarm this viral defense strategy and thereby restore antibody activities against CMV that are expected to contribute to future effective treatments.